Control of epidermal self-renewing populations by bHLH and MAPK regulatory system

Summary Self renewal is integral to the creation and maintenance of many tissues and organs including human epithelia, muscle and blood systems. Each of these tissues establishes populations of self-renewing (stem) cells and must ensure that these stem cells divide and create new differentiated cells at the appropriate rate and in the appropriate place; not enough cells or divisions and the tissue will deteriorate, too many divisions and tumors can form. Our long term goal is to understand the mechanism(s) by which dispersed self-renewing populations are established and how their division and differentiation is influenced by interaction with neighboring cells. A powerful set of genetic, molecular and functional genomic tools, combined with the ability to visualize and track cell divisions makes Arabidopsis stomatal development an attractive system for investigating this set of questions. In our previous work we found that a trio of bHLH transcription factors and components of a MAPK pathway modulate division vs. differentiation choices at discrete stages in stomatal development. Based on data from genetic, biochemical and functional assays, we propose that activity of the earliest-acting bHLH in this trio, SPEECHLESS (SPCH), controls the asymmetric divisions that create the self-renewing populations. We show that SPCH is a direct target of MAP kinase-dependent phosphorylation in vitro, and that phosphorylation alters the behavior of SPCH in vivo. Our specific aims in this proposal are to: (1) elucidate the molecular mechanisms by which SPCH activity is regulated (2) Create a molecular profile of stomatal lineage cells and identify and functionally characterize transcriptional targets of SPCH in these cells, and (3) Take advantage of SPCH-induced phenotypes to genetically dissect the endogenous signaling network required to repress stem-cell differentiation. Because both the bHLH class of transcriptional regulators and the MAPK pathway are universally conserved, these studies may contribute not only to an understanding of self-renewal, but will contribute to our understanding of the diversity of MAPK and bHLH signaling mechanisms and responses.

Public health relevance
Project Narrative Adult stem cells are called upon to regenerate or repair tissues following injury or disease. However, excess division of those same stems can lead to cancer. The proposed studies will thus help to inform strategies to induce stem cells to differentiate into specific tissues while restricting the potential for cancerous overgrowth. __SpecificAimsTextDelimiter__ a. SPECIFIC AIMS Self-renewing cells are integral to the creation and maintenance of many tissues and organs including human epithelia, muscles and blood systems. These diverse tissues must establish populations of self- renewing (or stem) cells in discrete locations and ensure that these cells divide and create new differentiated cells at the appropriate rate and in the appropriate place. Our long term goal is to understand the mechanism(s) by which dispersed self-renewing populations are established and how their division and differentiation behavior is directed by interaction with neighboring cells. A powerful set of genetic, molecular and functional genomic tools, combined with the ability to visualize and track cell divisions makes Arabidopsis stomatal development an attractive system for investigating this set of questions. Our focus in this proposal is on SPEECHLESS, a master regulator of stem-cell initiation. Using our unique set of SPEECHLESS protein variants we can separate division and cell fate promoting activities of this transcriptional regulator. Using SPEECHLESS variants in conjunction with isolated pure populations of specific stomatal precursors will enable us to identify its transcriptional targets and generate a gene expression profile of self-renewing epidermal cells. We further test specific hypotheses about the mechanisms by which SPEECHLESS is post-translationally regulated by MAP kinases and use the genetics of the system to dissect signals that act on self- renewing epidermal cells to control their proliferation and ultimate fates. Aim 1: Elucidate the molecular mechanisms by which mutations in MAPK target residues lead to alterations of SPEECHLESS stability and/or activity. We have found the transcription factor SPEECHLESS (SPCH) to be necessary and sufficient for asymmetric divisions that create self- renewing cells in the stomatal lineage. Our preliminary evidence indicates that a domain of SPCH is a substrate for phosphorylation by MAP kinases in vitro and is critical for SPCH function in vivo. To test several specific hypotheses about the mechanisms of SPCH regulation, we propose to: (i) Use results from functional and MS-based phosphorylation assays of SPCH to design SPCH variants with altered activities, (ii) Develop a preliminary profile of the identity and division potential of self-renewing stomatal lineage cells, (iii) Establish canonical lines of SPCH variants and characterize their behavior in lineage and cell fate assays, (iv) Assay the effect of mutations in MAPK target residues on SPCH protein persistence in the stomatal lineage, and (v) Monitor genetic and physical interactions between SPCH and potential dimerization partners ICE1 and ICE2. Aim 2: Create a molecular profile of stomatal lineage cells and identify and functionally characterize transcriptional targets of SPCH in these cells. Using transcriptional profiling, chromatin immunoprecipitation and FACS-isolation of stomatal lineage cells, we will create a comprehensive picture of genes expressed and required for stomatal lineage self-renewing cell fate and function. To dissect the regulatory hierarchies within this system, we will identify direct and secondary targets of SPCH. Here we propose to: (i) Identify gene expression changes upon induction of SPCH, (ii) Identify direct targets of SPCH using Chromatin IPs, (iii) Establish the transcriptional profile of self-renewing epidermal cells harvested by FACs, (iv) Combine datasets from subaims 2i-iii to define the set of genes most likely to be targets of SPCH and use genetics (loss and gain of function) to test the function of these genes in self-renewal or in stomatal differentiation, and (v) Extend FACs analysis to additional stages in stomatal and epidermal development. Aim 3: Take advantage of SPCH-induced phenotypes to genetically dissect the signaling network required to repress stem-cell differentiation. Through manipulation of SPCH and MAPKs we have also uncovered components of a negative regulatory system that acts on the cells produced by SPCH activity. This system prevents stomatal differentiation when those cells are in inappropriate cellular contexts. Having identified several members of the MAPK signaling pathway involved in this process, we will extend the analysis of this extensive gene family by testing the function of other MAPKs and MAPKKs in repressing differentiation. We will then take a non-biased approach to identifying additional regulations of this decision in a genetic screen. Here we propose to: Use SPCH misexpression as a sensitized background to (i),test additional MAPKs and (ii) identify novel regulators of SPCH-dependent stem cell creation and differentiation.